METABOLIC STUDIES--INSULIN CLAMP STUDIES IN MYOTONIC DYSTROPHY

Evaluation of the potential effect that insulin elevation by itself might have in producing an enhancement of tissue insulin sensitivity.